Evaluating telementoring to initiate a multidimensional diabetes program for Latino(a)s in community clinics: A Randomized Clinical Trial

PROJECT SUMMARY/ABSTRACT
Diabetes is a major public health problem in Latino(a)s. There are escalating numbers of Latino(a)s
diagnosed with diabetes and at disproportionate rates compared to other ethnicities. Numerous interventions
have been initiated to improve minority healthcare including diabetes group visits, which have been valuable in
improving education and glycemic control. In our group visit investigations, we initiated Community Health
Workers (CHWs)—local community members who serve as culturally-sensitive patient liaisons to the healthcare
system—as part of the multidisciplinary team. We demonstrated that CHWs are vital team members and
particularly helpful in identifying medication-access barriers. However, CHWs are frontline workers and often
left unsupported and poorly supervised. We used these data to pioneer the combination of four diabetes
interventions in our TIME trial (Telehealth-supported, Integrated CHWs, Medication-access, group visit
Education). The TIME trial showed that individuals randomized to TIME significantly improved glycemic control,
blood pressure and adherence to American Diabetes Association standards compared to usual care. The study
also showed that telehealth (mobile health (mHealth) and ZOOM video conferencing) was instrumental in
supporting CHWs in their work and enhancing their communication with patients.
The COVID-19 pandemic has highlighted the expansive use of telehealth and its ability to improve
healthcare. It has also underscored the pressing need to improve care for low-income minorities. Though
diabetes programs are valuable in improving education and clinical outcomes, they are often difficult to initiate
in low-income settings. Pragmatic implementation using telehealth to mentor local clinic teams of providers and
CHWs is promising to address these barriers. We have pilot data showing the feasibility of telementoring a local
clinic to initiate TIME that has resulted in improved HbA1c levels but we now need to test it within a larger sample.
In the proposed study we will evaluate this approach in a randomized clinical trial (N=250; intervention=125) of
low-income, adult Latino(a)s with type 2 diabetes randomized to TIME (intervention) versus usual care enhanced
with education (EUC). Our research group will provide telementoring to local clinic teams to initiate TIME into
their clinics. To evaluate efficacy, we will compare TIME versus EUC clinical changes including HbA1c (primary
outcome), blood pressure, cholesterol, and body mass index from baseline to 12-months (AIM 1). To compare
longitudinal data of study arms, we will follow these clinical measures until 36 months (AIM 2). We will also
provide TIME program acceptability and evaluation data for participants and clinic teams from baseline to 12-
months (AIM 3). We hypothesize that TIME participants will have superior and more sustainable clinical
outcomes compared to EUC individuals and that the intervention will have high levels of acceptability and
evaluation data. We anticipate that the proposed study will provide justification of telementoring to initiate TIME
and strong evidence to improve the longitudinal care of low-income Latino(a)s with diabetes.

Public health relevance
PUBLIC HEALTH RELEVANCE/PROJECT NARRATIVE Diabetes care is complex and requires a multidimensional approach, but interventional programs are difficult to initiate in low-income and minority populations. In the proposed study, we will mentor local clinics via telehealth to initiate our diabetes program, TIME (Telehealth-supported, Integrated CHWs, Medication-access, group visit Education), into their clinics. Mentoring local clinics to initiate TIME is a promising strategy to enhance sustainable diabetes care and reduce disparities in vulnerable minority populations.